Queensborough Community College Bridges to Baccalaureate Program

Project Abstract
This Proposal is a competing continuation application for the existing Bridges to the
Baccalaureate Program (GM065096) at Queensborough Community College (QCC). The
partnership between QCC, Queens College and City College, three units of the City University
of New York, will be maintained and strengthened to achieve the long term goals of improving
QCC’s ability to train and graduate under-represented (UR) science students, and to facilitate
their transfer to baccalaureate programs in biomedicine or behavioral science.
The proposed program will impact on both Bridges and non-Bridges students. The
Bridges students will conduct research under the supervision of experienced biology, chemistry,
physics, math and behavioral science faculty mentors. These research mentors will serve as
role models and provide students with encouragement, career advisement and visibility within
the academic community. Scientific communication skills will be explicitly taught, and each
student will give an oral presentation and submit a written report at the program wide seminar. A
comprehensive system of academic and psychosocial support will be provided to participants.
Transfer counseling and early interaction with the senior colleges will ease transition to
baccalaureate programs.
Institutional UR outcomes will be improved through enhanced academic planning,
curricula development, updated technology in teaching labs, faculty development, and the
introduction of peer mentoring. Enrichment Workshops will be provided to students in
General Biology I and Pre-Calculus to help them get beyond the “gateway” to careers in
biomedicine. The Gateway to Research workshops will help increase self-efficacy and eliminate
student misconceptions about research. In addition, students will continue to learn of the
excitement and significance of biomedical research through the Bridges Research Seminars. The
project’s goals are closely aligned with those of the NIH and will serve to increase the number of
URM students in the biomedical/behavioral science pathway, a key factor in reducing health
disparities.

Public health relevance
Project Narrative The goals of Queensborough Community College’s Bridges Program are closely aligned with those of the NIH and will serve to increase the number of underrepresented students in the biomedical/behavioral science pathway, which will help improve public health by reducing health disparities.